Core B: Neuroscience Core

Summary / Abstract
The objective of the current program is to advance our understanding of the molecular and neurocircuitry
mechanisms within the brain that control cardiovascular function and energy metabolism. The Neuroscience
Core is designed to provide critical equipment and technical support for studying neural mechanisms affecting
cardiovascular and metabolic functions that will be employed by all four projects within the program.
Investigators will have a full access to an array of equipment through this core to achieve the goal of proposed
studies that involve brain-region-specific gene manipulation, chemogenetic approach, multi-fiber recording of
regional sympathetic nerve activity, and histological examination of the brain. In addition, the Directors and
core staff will provide all necessary surgical support and training for all projects. The centralization of these
endpoints into a core will ensure scientific rigor and reproducibility of all proposed experiments that will use
advanced neuroscience techniques across the program.

Public health relevance
Project Narrative The objective of this core is to centralize the resource and equipment available and optimize the neuroscience methods to be used across the program. The core will provide all necessary technical and intellectual support for exploring neural mechanisms affecting cardiometabolic control, using advanced neuroscience techniques. In addition, the Core will provide all necessary training for all projects within the program.